Lung Cancer Immunotherapy using new generation of TCR-engineered CD4 + T cells

Abstract
Lung cancer is the leading cause of death among men and women in the U.S and world. The majority of non-
small cell lung cancer (NSCLC) is diagnosed at an advanced stage. Lung cancer treatment has made tremendous
progress in the past decade with advances in targeted therapies for EGFR, ALK, ROS1, MET exon 14 skip
mutation, RET, NTRK, and most recently KRAS G12C along with immune checkpoint blockade (ICB) therapy,
which shows 20% clinical response rate in lung cancer. Despite these advances, most patients will ultimately die
of the disease. Thus, lung cancer remains an unmet medical need for development of novel therapeutics. The
rationale for this application is that clinical responses to immune checkpoint therapy rely on the presence of tumor-
infiltrating and antigen-specific T cells. Thus, development of tumor-specific T cell receptor-engineered-T cell
immunotherapy is key to the success of immunotherapy in lung cancer. Because of the nature of tumor
heterogeneity, antigen loss or negative tumor variants represents a key mechanism to develop resistance to
immunotherapy. To address this issue, we recently developed academic (University of Southern California) -
industrial (Immunova Therapeutics LLC) partnership to facilitate translational development of CT83-specific TCR-
engineered CD4+ T cell product. CT83 is a cancer-testis antigen and is highly expressed in 40-60% of NSCLC.
Furthermore, MHC-II molecules have been documented to express in lung cancer samples. To further improve its
therapeutic potential, we generated an affinity-enhanced TCRM50A along with incorporation of three key
technologies to reduce potential risk of TCR-mispairing, increase the pools of stem-like memory T cells and resist
to T cell exhaustion and immune suppression. We named the final product as MHC-II-restricted CT83-specific
CD4-dependent (MIIC4) TCRM50A-STEM2 T cells (or IMT-423) and demonstrated its robust antitumor activity in
vitro and in vivo. Based on these solid data, we propose to determine the mechanisms by which MIIC4 TCRM50A-
STEM2 T cells eliminate lung cancer cells (Aim 1); produce good manufacturing practice (GMP) grade master cell
bank and viral particles and develop scale-up process of TCRM50A-STEM2 T cell manufacturing (Aim 2); and finally,
we will determine the biodistribution and toxicity of TCRM50A-STEM2 T cells, prepare and submit an IND
(investigational new drug) application to Food and Drug Administration (FDA) (Aim 3). The positive outcomes will
advance the development of TCR-T cell immunotherapy for lung cancer patients, and perhaps spur for the
development of immunotherapy for other CT83-positive cancers.

Public health relevance
PROJECT NARRATIVE Lung cancer is a leading cause of cancer-related deaths of men and women in the United States and worldwide. This Academic and Industrial Partnership R01 application is to develop a novel T cell receptor-engineered CD4 T cell immunotherapy by targeting cancer-testis antigen CT83. To further improve the therapeutic potential, we generated affinity-enhanced TCR in combination of several key technologies. The therapeutic candidate is named as MIIC4 TCRM50A-STEM2 T cells. The positive outcome of our proposed studies through USC and Immunova partnership will accelerate the development of therapeutic TCR-T cell immunotherapy drug, and shift the paradigm by paving the way for the development of new generation of immunotherapy for lung cancer treatment.